Developmental Research Program

PROJECT SUMMARY/ABSTRACT
The goal of the Developmental Research Program (DRP) of the SPORE in Bladder Cancer at Memorial Sloan
Kettering Cancer Center (MSK) is to support innovative translational research projects in urothelial cancer by
establishing mechanisms for rapid funding. Developmental Research Program funds in the SPORE in Bladder
Cancer, supplemented by institutional funds, will allow us to support projects by new and established
investigators that are critical to the generation of new ideas in the prevention, diagnosis, and treatment of
urothelial cancer. We will request proposals for urothelial cancer pilot projects with translational potential from
clinical and basic investigators within the larger MSK community, including Rockefeller University and Weill
Cornell Medical College. After rigorous peer review by the DRP Directors, Internal and External Advisory
Boards, and the Patient Advocate, the most promising new projects from this wide portfolio of developmental
research projects will be selected. Preference will be given to projects that complement the long-term research
goals of the SPORE and advance our translational research objectives. The DRP may also solicit and fund
experimental or clinical initiatives that address an urgent and specific need in the MSK SPORE in Bladder
Cancer program or a unique research opportunity. Eligible pilot project applicants to the DRP must have an
MD, MD/PhD, or PhD degree in a relevant area of research, be appointed as faculty members at MSK or
affiliated institution (Weill Cornell Medical College, Rockefeller University), demonstrate commitment to an
academic career in translational research related to urothelial cancer, and agree to participate in all relevant
conferences and activities related to the MSK SPORE in Bladder Cancer for the duration of support. The DRP
is committed to adhering to and supporting the MSK policies and procedures to promote diversity and
strengthen the participation of women and individuals from underrepresented minorities.

Public health relevance
PROJECT NARRATIVE Urothelial cancers include carcinomas of the bladder, ureters, and renal pelvis. As a public health concern, bladder cancer is the fifth most common cancer in the United States. The translational research projects in the Developmental Research Program aim to use knowledge of animal and human urothelial cancer biology to develop and test interventions related to the prevention, early detection, diagnosis, prognosis, and treatment of urothelial cancer.